Detecting Reversal of Apoptosis in Cancer Cells in Mice

Detecting Reversal of Apoptosis in Cancer Cells in Mice
Project Summary
Targeting apoptotic pathways is one of the most important therapeutic strategies for cancer treatments,
and primary cancers often exhibit dramatic initial responses to such treatments. However, most
metastatic cancers inevitably recur, leading to treatment failure. The classical view of apoptosis has
long assumed that, once initiated, this cell suicide process is irreversible. Challenging this assumption
is our recent highly original discovery that apoptosis can be reversible, even at late stages, in multiple
human cancer cell lines in vitro. We named this cell recovery mechanism “anastasis”, which means
“rising to life” in Greek. Removal of a death stimulus is sufficient to allow anastasis to occur, thus
indicating that anastasis is an intrinsic recovery phenomenon. We hypothesize that anastasis is an
unexpected escape tactic used by cancer cells to survive cell-death-inducing cancer therapy, thereby
causing cancer recurrence. If this hypothesis is true, anastasis would be a novel therapeutic target for
suppressing cancer recurrence and progression. However, anastasis in cancer cells in vivo has yet to
be demonstrated, and the consequences of anastasis remain undiscovered. To detect anastasis in live
animals, we have successfully developed a new biosensor to label anastatic cells in fruit flies, by
fluorescently tagging cells that have reversed apoptosis. This permanent tag is a unique tool for
detecting and following the consequences of anastasis in vivo. Here, we will apply the similar strategy
to detect and track anastasis in cancer cells in mice. By incorporating biosensor-expressing human
cancer cells with three clinically relevant xenograft mouse models of cancer relapse, we will determine
whether anastasis occurs in cancer cells in vivo, and if identified, whether it contributes to recurrence
after anti-cancer therapy. Our results will lay a strong foundation for developing anastasis-targeting
anti-cancer therapy, by generating essential animal models for studying the consequences of anastasis,
and by revealing the therapeutic potential of harnessing anastasis to suppress cancer recurrence.

Public health relevance
Project Narrative Cancer recurrence is a major problem in the clinical management of most types of cancer, but its mechanism remains unclear. Anastasis is a newly discovered cell recovery mechanism that dying cancer cells could adopt to escape cell death-inducing cancer therapy by reversing apoptosis and therefore contribute to the recurrence, but it is technically challenging to test this iconoclastic hypothesis, because at the present time there is no practical way to identify anastatic cancer cells. Here, we will apply a novel biosensor to detect and track anastatic cells – an essential tool to examine the contribution of anastasis in cancer cells to the recurrence.